Lymph-Borne Melanoma-Derived Proteins as Determinants of Lymph Node Metastasis

PROJECT SUMMARY
Tissues are primed for metastasis prior to the arrival of tumor cells. Primary tumors drive this transformation by
shedding tumor-derived factors (TDFs), including extracellular vesicles and secreted/shed proteins (TSPs) into
tumor-associated blood and lymphatic vasculature. Despite being the most common site of metastasis across
solid tumor types, we know very little about how the lymph node (LN) is primed for metastasis by TDFs. My
preliminary data demonstrates that primary melanomas initiate remodeling in their draining LNs that enhances
metastatic outgrowth relative to contralateral, non-draining and naïve LN controls. Furthermore, I have
demonstrated that TDFs uniquely activate this pro-metastatic LN phenotype rather than factors derived from
benign dermis or mouse albumin. The focus of this field has been on the role tumor-derived extracellular vesicles
play in establishing this pre-metastatic niche, however my data further demonstrates TSPs are also sufficient to
activate this niche. Using a novel cell-specific labeling strategy termed BONCAT (biorthogonal non-canonical
amino acid tagging), I have identified several candidate TSPs transported to the pre-metastatic LN. In this
proposal, I will test the hypothesis that TSPs initiate reprogramming events within resident cell populations of
the draining LN that support metastatic growth through two specific aims. The first aim will employ a scRNAseq
approach to identify cellular networks, TSP-induced crosstalk between the resident LN stroma and seeded tumor
cells, that provide trophic support to metastatic cells and the extent to which LN lymphangiogenesis is required
for LN metastasis. The second aim will investigate a specific TSP I have identified, CSPG4 (Melanoma-
Associated Chondroitin Sulfate Proteoglycan). This protein is shed by melanoma cells, has known melanoma
cell-intrinsic roles of invasion and is elevated in human melanoma patients, yet, it is unknown whether this TSP
contributes to pre-metastatic niche formation in distant sites. The completion of this work will provide foundational
information on TSP-dependent pre-metastatic niche development in the tdLN, and may uncover CSPG4 as a
novel driver of niche development. The proposed work will provide me with comprehensive training opportunities
integrating new bench techniques with high dimensional data analysis, ultimately preparing me for a modern
independent career as a researcher. Other training opportunities proposed will strengthen my professional skills
in writing, presenting, teaching/mentoring, and networking, laying the foundation for my long-term goals of
leading a research lab at an academic institution. My training objectives are supported by my sponsor (Dr.
Amanda Lund; Departments of Dermatology and Pathology) and co-sponsor (Dr. Itai Yanai; Departments of
Biochemistry and Molecular Pharmacology and Director of the Institute for Computational Medicine) who bring
expertise in cancer biology and immunology, and sequencing data analysis and integration, respectively.

Public health relevance
PROJECT NARRATIVE Metastasis is the leading cause of all cancer-related deaths, and the lymph node is a common first site of metastasis across solid tumor types, despite its anti-tumor immune function. Metastasis is preceded by molecular communication between primary tumors and future metastatic sites, and while there is appreciation for tumor- derived extracellular vesicles in pre-metastatic niche formation, we don't understand how tumor-secreted proteins (TSPs) may condition the “soil” for the “seed”. The successful completion of this proposal will identify the TSP-dependent lymph node reprogramming events that directly support metastatic tumor growth, and evaluate a candidate TSP identified in preliminary experiments that may prime the lymph node for metastasis.